SYMPOSIUM ON STREPTOCOCCAL GENETICS

The demonstration that DNA was the principle that transformed Streptococcus pneumoniae from rough to smooth colony type is broadly viewed as the event that launched the era of molecular genetics, the cornerstone of modern biotechnology. Streptococcal genetics have continued to be at the forefront in developing biotechnologies for application in manufacturing, such as dairy, meat, and silage fermentation industries; the production of novel streptokinases in the pharmaceutical industry; and for determining the structure and function of numerous virulence factors in human and veterinary disease. Investigators from these diverse fields who have made major contributions to the rich history of streptococcal genetics, as well as young aspiring investigators from across the globe will be brought together in Santa Fe, NM, for the IVth International ASM Symposium on Streptococcal Genetics. The proposed conference is scheduled for May 15-18, 1994 at the Eldorado Hotel in Santa Fe, New Mexico. The organizers of the conference are: Dr. Joseph Ferretti (Streptococci), Department of Microbiology and Immunology, University of Oklahoma Health Sciences Center, Oklahoma City, OK 73190; Dr. Michael Gilmore (Enterococci), Department of Microbiology and Immunology, University of Oklahoma Health Sciences Center, Oklahoma City, OK 73190; Dr. Todd Klaenhammer (Lactococci), Department of Food Science, Box 7624, North Carolina State University, Raleigh, NC 27695. This proposal requests $ 15,000 in direct cost funds to assist in support of this American Society for Microbiology sanctioned conference. Funds obtained from NIH will be used to support travel, registration, and meeting expenses for students, post-doctoral fellows, and speakers addressing central issues on the genetics of streptococcal virulence. The total conference budget is estimated to be $70,000. Additional funds are being solicited from NSF, USDA, industry, and other interested groups.